Investigating the role of cerebral perfusion in demyelination and repair in multiple sclerosis with MRI

PROJECT SUMMARY / ABSTRACT:
Multiple sclerosis is a chronic, debilitating disease of the central nervous system characterized by
neuroinflammation, focal demyelination, gliosis, axonal degeneration, and neuronal loss. As remyelination is
both highly variable and associated with improvement of symptoms, therapies that foster remyelination represent
an opportunity for repair prior to irreversible damage and decline. Given the importance of myelination, magnetic
resonance imaging (MRI) biomarkers of myelin integrity have been developed for use in clinical trials.
Unfortunately, these biomarkers reflect static levels of myelin and cannot predict demyelination or remyelination
processes. Recent studies have suggested that remyelination relies on adequate tissue perfusion. While altered
perfusion has been reported in MS, the relationship between perfusion and myelin has not been fully
characterized in vivo. Furthermore, whether perfusion MRI biomarkers can predict downstream myelin repair
remains an outstanding question. This proposal aims to overcome this challenge by investigating the role of
perfusion in demyelination and remyelination using MRI biomarkers. The development of biomarker assays to
quantitatively probe both perfusion and myelin content may predict regenerative potential and evaluate emerging
therapies that promote neuroprotection and remyelination. To assay perfusion changes, a multi-contrast spin-
and gradient-echo (SAGE) MRI method enables evaluation of hemodynamic measures at distinct vascular
scales (i.e., total vascular and microvascular regimes). Given the known microvascular component of MS, the
ability to specifically quantify microvascular function may provide a more specific indicator of underlying
pathology. Myelin content can be assayed using a selective inversion recovery (SIR) method that provides
quantitative and reliable measures of myelin. The objective of this study is to determine whether vascular function
is indicative of lesion demyelination and remyelination. More specifically, this project aims to a) establish the
relationship between perfusion and myelin in persons with relapsing-remitting MS (pwMS) and in healthy
controls; b) establish normative values in healthy controls and test-retest repeatability in both healthy controls
and pwMS with stable disease; and c) assess whether lesion perfusion predicts demyelination and remyelination
in pwMS with active lesions. If successful, this approach will establish the role of microvascular changes as a
precursor of disease and prognosticator of outcomes, as well as provide potential treatment targets related to
preventing microvascular dysfunction and its downstream effects. The development of robust MRI biomarker
assays that quantitatively probe both perfusion and myelin content could more reliably, and with greater
biospecificity, assess regenerative potential and therapeutic response, thus filling a critical gap in both patient
care and clinical trials designed to evaluate emerging neuroprotective and remyelinating therapies. Moreover,
this approach may provide insight into the complex factors that contribute to both lesion formation and resolution.

Public health relevance
PROJECT NARRATIVE: This goal of this proposal is to investigate the role of brain perfusion in lesion demyelination and repair in multiple sclerosis using imaging biomarkers. Complementary biomarkers of myelin and perfusion will be assessed in patients with MS and in healthy controls. These studies will yield insight into whether brain perfusion predicts changes in myelin associated with lesion repair.